Dynamics of hematopoietic differentiation

We finalized a manuscript detailing our most recent experimental results and modeling effort. This paper was submitted to biorxiv and is being adjusted to address reviewers' comments. Homeostatic hematopoiesis is a dynamical process, characterized by large variations of cell frequencies, cell proliferation rates and extensive correlations/anti-correlations within the myeloid lineage or the lymphoid lineage, and between lineages. All cell types exhibit rare but synchronized bursts of proliferation in the bone marrow, blood and spleen. We show that this abnormal cell accumulation drives the chaotic behaviors of blood cell counts to oscillations, of functional significance for leukemia and neutropenic patients. Our quantitative measurements and model challenge the textbook understanding of hematopoiesis at homeostasis, opening new avenues of research for immunotherapeutic manipulations.